A CURATED PROTEIN DOMAIN DATABASE FOR GENOME ANNOTATION

DESCRIPTION: (Adapted from applicant's abstract): The proposal describes the development of a comprehensively curated database for protein domains to extend the power of the existing protein domain databases for genome annotation. The new Proteome Domain Database (PDD) will complement the other comprehensively curated species-specific databases (YPD and WormPD) developed by Proteome, Inc. Which are already valued resources for annotation of new genome sequences. Like YPD and WormPD, the new Proteome Domain Database will be built Primarily by extensive curation of the research literature to capture Experimental knowledge of properties and functions of the previously Identified protein domains. The PDD will present to users and genome Annotators comprehensive information on the known functions, Regulations, Interactions, and modifications of the protein domains, and through the Existing knowledge will be deeply Integrated with the extensive knowledge already gathered for the Characterized proteins of model organisms. The PDD will be used by Pharmaceutical, biotechnology, genomics companies to add value to their Genomic sequence databases, leading to better understanding of cellular Pathways and selection of drug targets. PROPOSED COMMERCIAL APPLICATION: NOT AVAILABLE